Behavioral and Neural Correlates of Adaptive Risk-Taking Behavior in Preschool-Aged Children

PROJECT SUMMARY
Although risk-taking is traditionally associated with maladaptive outcomes, accumulating evidence suggests that
risk-taking facilitates implicit learning which, consequently, improves a variety of social behaviors. Despite these
findings, the adaptive utility of risk-taking behaviors during early childhood is often overlooked, causing missed
opportunities to improve concurrent and future developmental outcomes. It is critical that the adaptive role of
risk-taking is characterized during the preschool years, when the neural circuitry that underlies both risk-taking
behavior and social development is rapidly developing. Thus, the specific objective of this proposal is to examine
relations between risk-taking tendencies and adaptive phenotypes in preschool-aged children (4 and 5 years of
age). The central hypothesis of this proposal is that behavioral and neural markers of risk-taking will relate to
implicit learning and adaptive social behaviors in preschoolers. The rationale for this research is that the
identification of adaptive outcomes associated with risk-taking behaviors will inform clinical interventions and
educational practices that encourage appropriate and systematic risk-taking to bolster learning and social
development in young children. The central hypothesis will be tested through three specific aims: 1) To define
associations between risk-taking and implicit learning (Aim 1), preschool-aged children will complete a
computerized risk-taking task that relies on implicit learning. The rate of risk-taking behavior at the beginning of
the task will be compared to overall task performance to determine how exploratory risk-taking affects learning;
2) To delineate relations between risk-taking and social behavior (Aim 2), outcomes from the risk-taking task will
be correlated with caregiver- and teacher-report of children’s social behaviors obtained through gold-standard
assessments as well as a secondary risk-taking task designed to directly assess child engagement in social risk;
and 3) To identify neural mechanisms underlying risk-taking tendencies in preschool-aged children (exploratory
Aim 3), a separate sample of children will complete the risk-taking task while brain activity is simultaneously
recorded via electroencephalography (EEG). Outcomes from the EEG recording (e.g., event-related potentials
and spectral power) will be correlated with performance on the risk-taking measures. This proposal is innovative
because it is expected to provide strong scientific justification for the conceptualization of risk-taking as a dynamic
construct with adaptive outcomes including learning and social behaviors. This hypothesis contrasts the
traditional deficit approach to risk-taking during early childhood when risk-taking is presumed dangerous and
often discouraged. This work is significant because evidence of risk-taking as an adaptive behavior may reform
clinical and educational practices that discourage risk-taking behaviors. Furthermore, the use of EEG is expected
to elucidate new, mechanistic insights into neural correlates of risk-taking in preschoolers and, consequently,
inform clinical targets in populations that exhibit maladaptive risk-taking behaviors. This proposal also offers
unique training opportunities to undergraduates and will build research infrastructure at the PI’s home institution.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health and NIH’s mission because it examines the potential adaptive utility of risk-taking behavior during early childhood. Characterizing the adaptive role of risk-taking will create opportunities for significant optimization of both clinical interventions and educational practices intended to shape social development.